Examining Anti-Racist Healing in Nature to Protect Telomeres of Transitional Age BIPOC for Health Equity.

Summary:
The overall goal of this diversity supplement to the NIEHS U01 Reclaiming Nature parent grant is to provide
Dr. Ekland Abdiwahab, an African-American social epidemiologist, with training in biobehavioral research
methods, career development, and mentorship to support her transition into an independent research career
focusing on stress mechanisms underlying health disparities. Although there is a growing body of evidence that
Black, Indigenous, and People of Color (BIPOC) Transitional Age Youth (TAY) may use critical consciousness
to cope with racism-related stress and that critical consciousness is associated with civic engagement and
social-emotional well-being, there is very little understanding of the embodiment of critical consciousness. We
propose to investigate the relationships between discrimination-everyday discrimination and major experiences
of discrimination-critical consciousness, and telomere length among BIPOC TAY (ages 18-26). Attainment of
this research goal is expected to provide insight into racism-related mechanisms that contribute to accelerated
cellular aging and later-life chronic conditions among BIPOC populations and to investigate the development of
critical consciousness as a potential early-life intervention. As such it may be leveraged to reduce health
disparities in BIPOC populations. Taken together, the research experiences and career development activities
have been designed to cultivate Dr. Abdiwahab’s development into a transdisciplinary epidemiologist with
mixed methods training. Her training plan in year one focuses on coursework and directed readings on social
psychology and the embodiment of stress; biobehavioral research methods; strengthening her publication
record; participation in Reclaiming Nature group meetings; and attendance at national meetings and
workshops. In year two, she will develop a K-award proposal to build on the research accomplished in this
work for career advancement.

Public health relevance
Narrative: The overall goal of this diversity supplement to the NIEHS U01 Reclaiming Nature grant parent is to advance the career of an insider researcher who will achieve a greater understanding of biobehavioral stress mechanisms that underly health disparities in minoritized populations. This goal directly addresses the public health crisis caused by racism declared by many states, and agencies within the federal government.